Anti-Retroviral Activity of Human Endogenous Retroviruses

DESCRIPTION (provided by applicant): Understanding the role of endogenous retroviruses (ERVs), which make up ~8% of the human genome, is essential for understanding genome biology and evolution. Despite their prevalence and considerable contribution to the human genome being known for quite some time, an exhaustive and critical analysis of the coding potential from genes encoded by ERVs has not been carried out. I predict that the envelope (Env) encoded by ERVs has evolved novel anti- retroviral properties in primates, as analogous host defense systems have been observed in rodents, sheep, and chicken. I propose to conduct a bioinformatics-based screen for coding potential encoded by Env genes, as this already shows a propensity towards co-option. Preliminary work has already identified 2 intriguing candidates. I will also functionally evaluate these and other Env with coding potential for anti-retroviral activity and elucidate the route of restriction. The work proposed here will uncover a novel host defense mechanism in humans and other non-human primates, and further elucidate the impact of ERVs on their host and their role in genome evolution.

Public health relevance
PUBLIC HEALTH RELEVANCE: Retroviruses are a historical pathogenic threat, evidenced by millions of years old endogenization events into host genomes, and remain a present-day threat, as demonstrated by the HIV epidemic. The global aim of my research is to elucidate the role of endogenous retroviruses on host genomes and their impact on host genome evolution. This work will provide insight into the co-option and utility of endogenous retrovirus-derived genes by the host to better understand host defense mechanisms and genome evolution.